Cardiovasology

PROJECT SUMMARY
The mission of the “Cardiovasology” Training Program at Mayo Clinic is to address national needs in
developing, diversifying, and sustaining the next generation workforce in cardiovascular science and medicine,
and from whom new leaders in this multidisciplinary field will emerge. The renewal, for years 41 to 45, builds
on a legacy of excellence with demonstrated track-records in scientific proficiency and productivity, extramural
support and academic placement, contributing to the nation’s best practices for the betterment of health.
Drawing from the highest educational standards and cutting-edge technological platforms, “Cardiovasology” is
customized to match the background and career path of each trainee providing opportunities to widen interests
and expand capabilities in pursuit of evolving scientific advances. Heart failure is the central theme, informed
by morbidity and mortality trends. The interactive, diverse faculty of 32 funded subject matter experts from 11
departments, with robust mentoring records, enables team-science training across basic, translational, clinical
and population science tracks. Spanning tracks, curricula are practical, relevant and timely, and focus on
application of research methods to address patient needs optimizing the trainee's ability to challenge, refine or
create paradigms. Newly established local/regional/national transdisciplinary synergies expedite high-
throughput discovery and data mining, disease model interrogation, clinical trial execution, health disparities
research, and community outcomes. Program strength rests in leveraging Mayo Clinic investments in state-of-
the-art infrastructures and institutional priorities in individualized medicine, regenerative medicine, and science
of health care delivery, expanding the means for novel diagnostics, prognostics and therapeutics. Content in
disruptive innovation and deep learning (including artificial intelligence, augmented reality, advanced
biotherapies), and prominence in product development, regulatory science, and bio-business, further equip
trainees with the readiness to apply new know-how to combat heart failure burden and actuate the NHLBI
Strategic Plan. The renewal capitalizes on degree-granting programs, and attracts highly competitive MD,
MD/PhD, and PhD candidates from across the nation with a recognized emphasis on participation of women. A
history of strong recruitment and retention, supplemented with a fellow-to-faculty career development program,
has fostered the stepwise launch of competitive independent careers. Accordingly, “Cardiovasology” requests
the continuous support for six postdoctoral trainees. Committed to a community of diversity to attract high
quality candidates, provide trainees with essential skillsets and new competencies, the Program actively builds
the workforce of the future supplying the pipeline to meet a 2030 trajectory. The renewal underscores the
creative, innovative and dynamic vision of the “Cardiovasology” Training Program empowering the emerging
academic cadre to lead the way in turning science into cardiovascular health.

Public health relevance
PROJECT NARRATIVE The “Cardiovasology” Training Program at Mayo Clinic is an avenue for advanced training of the specialized workforce of physicians/scientists focused on heart health and disease. This proposal expands Program faculty and scope, deepens and broadens its scientific expertise, fosters diversity of mentors and trainees, and integrates new training in emerging technologies and innovations. This Program builds on a four-decades long history of excellence in attracting, mentoring and retaining talented individuals that will form the next generation of science leaders and scholars in this country.